University of Notre Dame Post-baccalaureate Research and Education Program

Project Summary/Abstract
The University of Notre Dame (ND) proposes to create a cross-university Postbaccalaureate Research Education Program
(ND-PREP) to provide a one year pre-PhD research experience for eight post-baccalaureate Fellows from underserved
diverse backgrounds. Through a combination of NIH support (six Fellows) and institutional funds (two Fellows), Fellows
will have the opportunity to choose a research laboratory associated with any of the biomedical-associated PhD
programs at ND. The specific sponsoring PhD programs are the Biochemistry, Biological Sciences, Biophysics, Chemistry,
and Integrated Biomedical Sciences (IBMS) programs in the College of Science, Bioengineering in the College of
Engineering, and the Anthropology and Psychology PhD programs in the College of Arts and Letters. The goal of ND-
PREP is to provide Fellows with the research experience, professional development, and life skills necessary to gain
admission to and succeed in competitive biomedical PhD programs and to do so in an environment that is rigorous
while also being individualized, interactive (with both peers and mentors), positive, constructive, and supportive. This
goal will be achieved by providing the Fellows with a three-part formal training program that includes: 1) an intensive
in-laboratory research experience (75% of Fellow time); (2) a set of skills-development workshops and enrichment
activities that will also serve to build a strong ND-PREP cohort (15% of Fellow time, with workshops ranging from
research ethics to life skills); and (3) Fellow participation in a unique community engagement activity (10% of Fellow
time). The skills-development workshops and enrichment activities will begin with an intensive Summer Graduate School
and Research Readiness Bootcamp followed by ND-PREP cohort weekly meetings throughout the academic year. Each
ND-PREP Fellow will gain further professional development by attending regional or national conferences. A unique
aspect of the ND-PREP program will be participation of Fellows in existing community outreach activities focused on
lead abatement. Beyond professional development training, each ND-PREP Fellow will have a mosaic of formal and
informal mentors who will provide more personalized training and mentorship. ND-PREP participants will apply to PhD
programs (including but not limited to ND) in the fall semester, after participating in writing workshops specifically
focused on writing competitive applications that highlight their strengths. Significantly, the set of Fellows who were
initially identified through the PhD program application process and who successfully complete the ND-PREP program
will be directly admitted to the PhD program that originally nominated them.Through the three-part training program
provided by ND-PREP, Fellows should gain the foundational research experience, professional development, and life skills
necessary for a life-long career in biomedical research.

Public health relevance
Project Narrative The University of Notre Dame proposes to create a Post-baccalaureate Research Education Program (ND-PREP) to provide a one year pre-PhD biomedical research experience for individuals from underserved diverse backgrounds. The goal of ND-PREP is to provide Fellows with the research experience, professional development, and life skills necessary to gain admission to and succeed in competitive biomedical PhD programs. This goal will be achieved by providing the Fellows with a three-part formal training program that includes: 1) an intensive in-laboratory research experience (75% of trainee time); (2) a set of skills-development workshops and enrichment activities that will also serve to build a strong ND-PREP cohort (15% of Fellow time, with workshops ranging from research ethics to life skills); and (3) Fellow participation in a unique community engagement activity focused on lead abatement in the local community (10% of Fellow time).